Infrastructure for mentored access to CHS data and specimens

ABSTRACT
Cardiovascular Health Study (CHS) is a population-based cohort study of 5888 older adults recruited in
the 1990s and designed to study traditional and novel risk factors for onset and course of heart disease and
stroke. Subclinical disease measures include pulmonary function, carotid ultrasound, echocardiography,
cranial magnetic resonance imaging and others. CHS originated the Working Group (WG) model that
provides mentored-access to CHS, an especially valuable model for early-career investigators. The CHS
WGs—Cardiovascular, Diabetes, Geriatrics, Neurology, Renal, Bone and Genetics—have been productive.
With more than 2120 publications, CHS has an h-index of 240. As of Dec 2023, CHS also has 78 active
ancillary studies, 41 of them currently funded by the NIH, and another 22 in revision or under review. NHLBI
contract funding for CHS has, however, not been steadfast. Contract funding for examinations ended in
1999. The surveillance calls did continue. In 2005, the NHLBI also ceased contract funding for events data
collection. An investigator-initiated grant (HL080295) supported events data collection until 2015. In 2016,
when the NHLBI ceased contract funding for CHS altogether, an investigator-initiated grant (HL130114)
continued support for the Biorepository, for ongoing surveillance calls to participants, and for the support of
working groups through 2020. A new NHLBI contract supports CHS until Oct 2024. In Nov 2024, about 25
of 60 CHS active ancillary studies will have NIH funding that persists beyond the end of the contract. Also,
TOPMed has just awarded CHS almost $10 million worth of multi-omics assays (8619 proteomics, 8619
metabolomics, and 8041 DNA methylation) with 3 timepoints as available for participants with WGS data.
At this time, the NHLBI lacks an NCI-like mechanism for infrastructure grants for epidemiology cohorts
(PAR-20-294), so the only option for CHS is again (as we did in 2016) to seek peer-reviewed R01 funding
even though the genre of infrastructure support differs from that of hypothesis-testing grants. The purpose is
to provide a scientific service and maintain a major research resource for the scientific community. None of
the study aims involves a hypothesis test, but these service aims enable the myriad hypothesis-based
activities of the CHS investigators and ancillary studies. The primary aims of this grant application are: 1) to
provide infra-structure support to maintain the CHS Coordinating Center, its various databases, and
activities, including support for 78 ancillary studies; 2) to assist investigators in developing grant applications
for new ancillary studies; 3) to provide support for the CHS Biorepository; 4) to provide mentored access to
CHS data and its specimens; 5) to provide limited support for 7 CHS Working Groups; 6) to make CHS data
and ancillary-study opportunities widely available to all investigators; and 7) to keep CHS active for critically
important participation in multi-omic and multi-study collaborations such as TOPMed. The findings from
CHS will be vital for developing novel CVD preventive strategies to improve the health of older adults.

Public health relevance
RELEVANCE Especially valuable with the award of multi-omics data from TOPMed, the proposed study provides infrastructure support for the Cardiovascular Health Study (CHS), including the Coordinating Center, the Laboratory/Biorepository, seven productive Working Groups, and mentored access to CHS data and specimens for all investigators. The CHS model represents a nimble method of investing modest resources in a high-quality research setting that exerts selective pressures for the emergence of innovative science and meritorious questions. The findings from CHS will be vital for developing novel CVD preventive strategies and for improving the health of older adults in the US.